Design principles for engineering therapeutic macrophages

PROJECT SUMMARY
Genetically engineered immune cells are an exciting and promising frontier for treating a wide range of
complex diseases. However, hyperinflammatory toxicities such as cytokine release syndrome plague clinical
trials, stymieing their widespread clinical adoption. Macrophages are innate immune cells that fulfill many roles
in tissue repair, regeneration, and homeostasis and are important regulators of inflammation. However, they are
significantly under-utilized as engineered immune cell therapies because significant knowledge gaps exist in
understanding how to engineer synthetic gene circuits that work robustly in human macrophages. Tools do not
yet exist for determining how macrophages should be biologically manipulated to activate desired effector
functions (biological design principles). Tools also do not exist for determining what gene circuit architectures
are needed to robustly induce desired gene circuit behaviors (gene circuit design principles). The overall goal
for this proposal is to create a human macrophage design toolkit for engineering therapeutic macrophages. Our
published and preliminary data demonstrate that we have developed tools that enable us to discover cell
signaling interventions that can control macrophage effector functions (biological design principles) and gene
circuit architectures that can exert robust behaviors in human macrophages (gene circuit design principles). Here
we will apply both these approaches to elucidate biological and gene circuit design principles that can be used
to engineer therapeutic macrophages that can suppress inflammatory cytokine secretion or induce anti-
inflammatory cytokine secretion in inflamed tissues. We will elucidate biological design principles using an
interpretable machine learning approach that we previous developed. This approach combines biochemical
screening with predictive network modeling and machine learning to discover network mechanisms causally
regulating cell phenotypes. We will elucidate gene circuit design principles using a recently developed ultra-high-
throughput genetic screening approach (CLASSIC). This approach synthesizes and screens large, barcoded
gene circuit libraries to associate gene circuit architectures with gene circuit behaviors. With these design
principles we will engineer gene circuits for controlling IL-1β or IL-10 secretion in inflamed tissue contexts and
validate these synthetic gene circuits in human monocyte-derived macrophages and THP-1 cells. In its entirety,
this Trailblazer R21 project is a first step towards addressing the unmet need for design principles for engineering
therapeutic macrophages. We envision that insights gained by this project will help establish engineered
macrophages as a platform technology for treating a wide range of complex human diseases.

Public health relevance
PROJECT NARRATIVE Genetically engineered immune cells are an exciting and promising frontier for treating a wide range of complex diseases. Macrophages are innate immune cells that fulfill many roles in tissue repair, regeneration, and homeostasis but that are significantly under-utilized as immune cell therapies because significant knowledge gaps exist in understanding how to engineer macrophage gene circuits. This project creates a gene circuit design toolkit for engineering therapeutic macrophages.